Parasitology and Vector Biology Training Program

7. Project Summary/Abstract
Parasitic diseases caused by protozoans and helminths, as well as arthropod-vectored viral diseases,
continue to plague much of the developing world. Even in industrialized nations, poorer communities are
deeply affected by parasitology and arboviral diseases, especially in the southern Gulf coast region of the
United States. The United States has also seen the emergence of new human pathogens (e.g., Cyclospora,
Chikungunya and Zika Viruses), as well as the re-emergence of well-known pathogens such as West Nile or
Dengue Viruses. What is needed to combat these devastating infections is a new generation of researchers
focused on parasitology and arboviral diseases; however, there are only a few NIH T32s focused on
parasitology and vector-borne infectious diseases. One of these T32s is the Parasitology and Vector
Biology (PVB) Training Program at the University of Wisconsin-Madison. The goal of the PVB training
program is to attract and train the next generation of parasitology/arboviral/vector biology investigators by
providing opportunities to study significant, cutting-edge research problems associated with the most
important neglected tropical diseases. This goal will be accomplished by trainees acquiring a solid
foundation of basic to advanced knowledge through formal coursework, small focus groups and seminars,
and combining this knowledge with the latest technologies to address challenging questions posed by a
variety of host-pathogen systems available in the laboratories of our 14 faculty trainers. Funding for this
renewal is requested for 5 years to support 4 predoctoral trainees per year. After matriculating into one of
three main graduate degree programs, new-entry or post-dissertator PVB trainees will be appointed for 2
years. In addition to meeting their degree program requirements, trainees also are required to complete a
research ethics course, complete an individual development plan and update it yearly, and present their
research annually in the PVB seminar series. In an effort to increase the diversity of graduate students
seeking advanced degrees in parasitology and tropical medicine, plans are described to identify and recruit
under-represented minority (URM) students. The plan enacted during the last cycle was highly effective as
half of our PVB trainees are URMs. Providing cutting edge and well-rounded training in molecular
parasitology and arboviral biology for predoctoral trainees has been and will continue to be our mission.
Given the worldwide need to combat these infections, we must train the next generation to think broadly
about parasite and arthropod-vectored diseases so that novel solutions to the devastation they cause can
be found.

Public health relevance
8. Project Narrative Diseases caused by protozoan and helminth parasites and arthropod-vectored viruses continue to affect millions of people in resource-poor developing countries, despite a vast accumulation of basic and clinical knowledge about these infectious agents. The goal of the current training program in Parasitology and Vector Biology is to recruit and train the next generation of investigators whose focus is on understanding the basic mechanisms regulating host-pathogen interactions and human transmission, thereby contributing to global efforts to control these devastating diseases.